Catalytic Coupling Reactions via C-H and C-N Bond Activation

ABSTRACT The major goal of the proposed research is to design and utilize novel catalytic C-H bond activation methods for the synthesis of complex organic compounds of phamaceutical importance. The first aim of the project is to develop and utilize the catalytic C-H coupling methods to synthesize a number of biologically active target molecules, including tamoxifen, celivarone and sulindac. The second aim of the project incorporates catalytic coupling method of amino acid derivatives via C-N bond cleavage to synthesize a number of complex molecules of pharmaceutical importance, including donepezil and STX-1040. The proposed research plan aims to develop novel catalytic coupling methods to synthesize a variety of high-value target molecules with potent anticancer and anti-inflammatory biological activities under environmentally sustainable conditions. The project seeks financial support of one postdoctoral associate and one graduate student to carry out the proposed project.

Public health relevance
NARRATIVE The long term goal of this research is to develop novel catalytic coupling methods directed to the synthesis of a variety of natural products and pharmaceutical agents under environmentally benign conditions. The major objective of the proposed research during the current project period is to utilize novel catalytic coupling methods via C-H and C-N bond activation to synthesize a number of complex organic molcules of pharmaceutical importance. The proposed research seeks to develop generally applicable catalytic coupling methodologies to synthesize a variety of high-value target molecules with potent anticancer and anti-inflammatory activity.